The Promoting Resilience in Stress Management (PRISM) Intervention: a multi-site randomized controlled trial for Adolescents and Young Adults with advanced cancer

PROJECT SUMMARY
Cancer among Adolescents and Young Adults (AYAs) is particularly difficult because age-related
developmental challenges of identity, relationships, and vocation may add to the burden of cancer. Compared
to other age-groups, AYAs have poorer psychosocial outcomes. Among AYAs with advanced cancer, too
many miss opportunities to express their hopes, worries and end-of-life preferences, translating to both patient
and parent distress. A potential barrier to improving these experiences may be that AYAs have few
opportunities to develop the personal resources needed to handle adversity and articulate their needs. We
have previously described the “Promoting Resilience in Stress Management” (PRISM) intervention for AYAs
with cancer. This manualized, brief intervention is delivered in 4, 30-60 minute, one-on-one sessions, followed
by a family meeting. It targets skills in stress-management and mindfulness, goal-setting, positive reframing,
and meaning-making. All of these skills are associated with improved patient well-being in other populations,
and findings from a recent pilot randomized controlled trial among AYAs with newly diagnosed cancer suggest
PRISM is associated with improved perceptions of resilience, lower psychological distress, and higher health-
related quality of life (HRQOL). This application proposes to build on our prior experience and fill three critical
knowledge gaps: (1) PRISM’s impact among AYAs with advanced (as opposed to early stage) cancer; (2)
Associations between AYA-PRISM participation and parent outcomes; and, (3) Associations between PRISM
skills and patient engagement in clinical decision-making. This funding opportunity seeks to test AYA-specific
palliative care interventions designed to positively impact HRQOL. Thus, we propose a multi-site randomized
controlled trial among N=144 AYAs (n=72 PRISM, n=72 Usual Care; ages 12-21) with the primary trial
outcome of patient-reported HRQOL 3 months following enrollment. Secondary outcomes will include patient-
and parent-reported anxiety and depression, and family “palliative care activation” (advocacy on behalf of
AYA’s hopes and worries, engagement in goals-of-care conversations, and utilization of formal palliative care
and psychosocial services). We hypothesize that AYAs who receive PRISM and their parents will report higher
HRQOL, lower anxiety/depression, and higher activation when compared to those who receive usual care.
This application offers an opportunity to expand the body of knowledge regarding methodologically rigorous
and evidence-based palliative care interventions and standards of care for AYAs with advanced cancer and
their families. Ultimately, this research has the potential to reduce the burden of cancer in these vulnerable
populations.

Public health relevance
PROJECT NARRATIVE Despite growing recognition of the disparate needs and outcomes of Adolescents and Young Adults (AYAs) with cancer, few age-specific or developmentally-appropriate palliative care interventions have been described for this population. Our proposed randomized controlled trial uses a novel, person-centered intervention designed to bolster patient-reported resilience, in turn improving communication and quality of life. If successful, results will greatly inform future research and clinical strategies aimed at easing suffering and improving outcomes among AYAs with cancer and other serious illnesses.